Imaging Core

ABSTRACT IMAGING CORE
The Imaging Core has been a central component of our COBRE, “Expanding Excellence in Developmental
Biology in Oklahoma” since the beginning of Phase I. Its mission is to provide state-of-the-art imaging
instrumentation, outstanding training programs, and commitment to fair access for researchers throughout
Oklahoma. Throughout Phases I and II, the Imaging Core has enabled COBRE investigators to utilize
sophisticated imaging approaches in the acquisition and analysis of their research data. The Imaging Core
has, in addition, contributed greatly to enhancing imaging infrastructure at OMRF, thereby expanding both
imaging capabilities and their access to all Oklahoma researchers. This contribution will continue through
Phase III. We will continue to support and develop the Imaging Core by providing advanced imaging
technologies to our Pilot Project Investigators and former Phase I and II COBRE Project Leads while moving
the Core towards post-Phase III sustainability. We will accomplish our goals through the following Specific
Aims:
Aim 1. Maintain a state-of-the-art imaging facility. Aim 2. Continue our strategy for advising and training
investigators in using the Imaging Core. Aim 3. Establish a sustainable Core budget.
Aim 4. Sustain methods for reviewing, prioritizing, and supporting projects. Aim 5. Sustain methods for
resolving Core usage disputes. Aim 6. Continue evaluating the efficiency and effectiveness of the Core. Aim 7.
Make a strategic plan to sustain the Imaging Core beyond COBRE Phase III.